CAMIPM-Tech-Training-Dissem

TECHNOLOGY TRAINING AND DISSEMINATION
ABSTRACT
The Center for Advance Metabolic Imaging in Precision Medicine (CAMIPM) will have a training and
dissemination core, which focuses on the training of next generation of scientists in center developed
technologies and dissemination of the center’s technologies across the country abroad.
Training efforts will also function as a means for new and established researchers to learn about the latest
developments in the field and to hone their skills for applications within their own research programs.
Investigators may be trained on an individual basis by CAMIPM staff or as a group by seminars, courses, and
workshops. The CAMIPM facility houses over 20 desks in a wall-less, cubicle-free environment, which promotes
open communication and discussions among all of its members and visitors. Training efforts will include: 1)
weekly or bi-weekly seminar series and group research meetings and monthly Radiology Research Rounds and
Advanced Biomedical Optics presentations, 2) hands-on training by dedicated center personnel, 3) courses
offered by CAMIPM faculty (7 courses), and 4) conference attendance.
Dissemination of CAMIPM knowledge, technologies and expertise will be distributed across several channels
including 1) annual workshops organized by its staff, 2) invited lectures by its personnel, 3) publications, 4)
conference abstracts, 5) CAMIPM website and social media, 6) patent disclosures via the Penn Center for
Innovation, and 7) transfer of software via Github.
CAMIPM will utilize professional video management and screen-capturing software to facilitate sharing
workshop presentations and training manuals, respectively. CAMIPM will incorporate cloud storage and video-
conferencing systems to expedite training and dissemination activities. We are confident that these strategies
will enhance the Center’s training and dissemination activities by targeting the next generation of scientists,
doctors, and trainees.